Improving outcomes in HIV-associated opportunistic infections using CNS pharmacokinetics and pharmacodynamics

ABSTRACT
Mortality from cryptococcal and TB-meningitis in individuals with HIV is unacceptably high and better
therapeutics are needed. The future landscape of treatment against these infections involves either
development of new therapeutics, which has been slow, and/or the optimization of current therapeutics with
improved formulations or dosing regimens. The CNS is a significant site of infection for these pathogens;
however, current understanding of drug penetration into the CNS is limited, based on cerebrospinal fluid (CSF)
concentrations. However, CSF is not brain tissue. Furthermore, pharmacokinetic targets for therapy have been
largely based on systemic or plasma concentrations with limited pharmacology assessments performed in CSF
or brain parenchyma. Improved understanding of drug exposure to and within the brain compartments where
pathogens reside, and how these exposures relate to pathogen clearance will be critical in the development
and optimization of effective regimens.
Our long-term objective is to reduce mortality from CNS infections. Herein, we aim to use
pharmacokinetic/pharmacodynamics modeling to:
1) define CSF drug concentrations or AUC/MIC ratios, that predict rate of fungal clearance
2) determine the relationship between CSF drug concentrations and with inflammation, resistance,
neurocognitive outcome, and survival
3) determine drug distribution in brain parenchyma using post-mortem specimens
This project builds on existing research collaboration, infrastructure, and progress made with our R21
NS108344. This project represents a unique synergy between existing strengths of the study team members.
Early stage-investigator Melanie Nicol, PharmD, PhD has advanced training in clinical pharmacology and
performing drug distribution and pharmacokinetic studies. Robert Lukande, MMed, PhD is an experienced
pathologist who can provide expertise in the performance and interpretation of autopsies. Drs. David Meya and
David Boulware are leaders in cryptococcal and TB meningitis and lead multiple clinical trials in these areas,
allowing us access to research participants on a variety of drug regimens. The findings from this R01 are
expected to fill critical gaps in our understanding of the dose-concentration-response relationships of antifungal
and anti-TB drugs for the treatment of CNS infections in individuals with advanced HIV and ultimately reduce
mortality with improved regimens. The R01 will also support critical infrastructure and capacity building in
Uganda in regards to drug distribution assays and the implementation of autopsy procedures.

Public health relevance
PROJECT NARRATIVE It is poorly understood how well the drugs used to treat deadly CNS infections in individuals with HIV actually penetrate into compartments of the brain. This study will leverage samples from CSF obtained during treatment, and brain tissues collected during autopsy, to define the concentrations of these drugs, and determine how well these drugs work in the brain to remove the infections.